STRUCTURAL AND FUNCTIONAL ANALYSIS OF PROTEIN SEQUENCE FAMILIES

To determine the relationships between the structure and the function of DNA- and RNA-binding families of proteins. Most of these protein families have the property of binding to DNA or RNA, for example, the HMG-1 box proteins, heat shock factors, ets proteins nd ribosomal proteins. The HMG-1 box family of proteins is not highly conserved and is represented by over 100 examples in the sequence databases. We have identified a signature for this family of proteins and have classified them into several groups according to their sequence and functional relation. In the past few years, numerous proteins have been identified as containing a stretch of about 75 amino acids which are homologous to an abundant non-histone chromosomal protein HMG-1. These proteins bind DNA and bends it on binding or bind preferentially to bent DNA. Several of these proteins have been implicated in numerous nuclear functions including transcription, replication, and chromatin structure as well as transcription regulation in mitochondria resulting, in some cases, in such phenotypes as sex and mating type determination. We have compiled and are maintaining a database of the HMG-1 box family of proteins and are analyzing the sequences to determine the phylogeny between these functionally widely-diverse proteins. Recently, the 3D structure of several HMG-1 box domains have been determined by multidimensional NMR. We have used one of these structure to model the other members of the family by a threading method. We have successfully produced models for the complete family of HMG-1 box domains. The conclusion drawn from these calculations is that these proteins are most likely to fold into similar conformations. We are using a threading technique to compare sequences of RNA-binding proteins to the 3D structures of several RNA- binding proteins, which includes many ribosomal proteins and a splicing factor. This method allows the determination of the ability of a sequence to fold into a particular known protein conformation. We are presently comparing ribosomal proteins to the known protein structures and are also modeling other RNA-binding proteins. An iterative motif search algorithms being used to detect new and as yet unidentified motifs of several families of DNA-binding and RNA-binding proteins. We have identified several proteins which contain domains which could be related to the histone fold of nucleosome octamer histones.